University of Maryland Center of Excellence in Regulatory Science and Innovation

Project Summary: In 2012, we established the University of Maryland, Center of Excellence in Regulatory Science (UM-CERSI) that involves the University of Maryland in Baltimore (UMB), the University of Maryland College Park (UMCP), and the FDA, with scientific exchange, research, academic, and outreach components. The Center's mission is to foster the development of regulatory science — the science of developing new tools, standards and approaches to assess the safety, efficacy, quality and performance of FDA-regulated products. The UM-CERSI has focused on three of the original FDA Regulatory Science Initiatives: 1) Improving pre-clinical assessments of safety and efficacy; 2) Ensuring readiness to evaluate innovative and emerging technologies; and 3) Harnessing diverse data through information sciences to improve health outcomes. In addition, we have established strong collaborations with the Office of Minority Health, spanning a variety of research thrusts. In the figure below, we highlight what has emerged as our most successful and visible initiatives: (1) our cutting edge research areas; (2) our monthly lectures; (3) our science exchange workshops; (4) our innovation awards, (5) our MS/MEng education programs; and (6) our America's Got Regulatory Science Talent competition. The sum of these activities represents a vibrant Center with a variety of activities. Our vision for the future wrests on these strengths while adding programs in support of one of the newest FDA priority areas: Supporting new approaches to improving product manufacturing and quality. The UM-CERSI enhances FDA efforts to advance regulatory science by providing: 1) direct scientific and training linkages to two leading UM campus; and 2) providing cutting edge regulatory science research experiences for teams of FDA and UM personnel in three collaborative projects. The UM-CERSI has Center-wide activities that promote regulatory science within the broader scientific community. It also links individual projects, each of which have education & training, and research activities.

Public health relevance
Project Narrative We propose continuation of M-CERSI that fosters scientific exchange, education and training, as well as FDA-oriented research, all focused on regulatory science. The Center is organized into Center-wide activities that cut across projects bringing diverse thoughts and ideas to all Center participants, and five Center foci, each of which advances scientific exchange and regulatory science research based on area-specific projects.